Effect of an Anti-Inflammatory Diet on Gut Homeostasis in Active and Experimental Crohn's Disease

Project Summary
The inflammatory bowel disease (IBD) subtype, Crohn’s disease (CD) is a chronic and relapsing inflammatory
disorder of the gastrointestinal tract. Although the precise etiology of IBD is not known, evidence suggests that
environmental factors, including diet, contribute to its pathogenesis.1-3 Specifically, dietary amino acids serve as
key regulatory factors in cellular and microbial metabolic pathways, and disturbances in their metabolism,3 as
well as altered presence of amino acid concentrations (blood/feces/urine), are observed in CD patients.4 Diet
has been shown to have a pro-inflammatory effect in CD, but not much is known about anti-inflammatory diets
(e.g., soy).5, 6 Gut microbial modulation via diet is a needed strategy for the therapeutic management of CD;
however, no specific recommendations exist for CD patients. Moreover, studies show that the person-specific
changes elicited by a dietary intervention on host immune/metabolic function reflect unique microbiota
signatures. This proposal will focus on the microbiota-mediated effects of dietary soy and individual amino
acid supplementation in patients with active CD compared to healthy controls. The central hypothesis of this
proposal is that a soy diet induces anti-inflammatory microbiota in CD patients and that the ‘level of response’
for each individual can be predicted by metabolic and microbiome biomarkers. We will test this hypothesis
directly in humans with active CD and mechanistically focus on the effect of dietary soy on the ‘pro-inflammatory
potential’ of gut microbiota in CD patients. Experimentally, we will use our validated human gut microbiota
SAMP1/YitFC; SAMP (hGM-SAMP) mouse model of CD-ileitis to quantify and mechanistically validate the
functional effect of human feces on the severity of CD-ileitis after transplantation into GF SAMP. As a main
objective, we will determine to what extent a soy-based diet could induce changes in fecal/blood inflammatory
biomarkers in patients with active CD. The following aims are a continuation of our efforts to understand the
microbiota-mediated effects of diet on intestinal inflammation. AIM 1: will characterize the effect of dietary soy
in humans with active CD and quantify the inflammatory potential of their gut microbiome using a ‘rapid screening’
hGM-SAMP DSS-colitis model. By stratifying inflammatory microbiome/blood markers, we will identify
biomarkers that could predict ‘responders’/‘non-responders’ to diet. We expect to generate a list of metabolic
and microbiome clinical biomarkers that could be used to monitor response to diet in CD patients. AIM 2: will
determine the impact of soy-associated amino acid dietary supplementation on the microbiome, metabolome
and immunology of a spontaneous CD-like ileitis in hGM-SAMP and SPF SAMP, and AKR control mice. We will
identify functional metabolic mechanisms associated with the severity of mouse CD-ileitis in response to diet.
This proposal is based on strong preliminary data in mouse models of IBD that a soy-based diet treats and
prevents the severity of intestinal inflammation. To translate this information to human CD represents a very
significant area of investigation in this field of research and will ultimately inform the direction of future studies.

Public health relevance
Project Narrative Crohn’s disease (CD) is a chronic, commonly disabling disorder of the gastrointestinal tract that is associated with imbalances in the composition of gut bacteria (‘dysbiosis’), and affects more than 600,000 individuals in the US. Gut bacteria modulation via diet is a needed strategy for the treatment and prevention of CD; however, no specific recommendations exist for CD patients, and little is known about the complex interaction between dietary nutrients, gut bacteria and host immune responses. Understanding these interactions, particularly how specific dietary factors can alleviate disease symptoms through their effect on the composition of gut bacteria, will allow us to develop novel therapeutic approaches to treat, prevent, and ultimately cure the disease.